An in vitro system to study antiviral strategies against Hepatitis C virus

[unreadable] DESCRIPTION (provided by applicant): The Description section was not included in the original submission of the amended application. [unreadable] [unreadable] [unreadable]